2014 AUA Urological Oncology Research Symposium: "Progress in Translational Urolo

DESCRIPTION (provided by applicant): R13 Application for the 2014 AUA Urological Oncology Research Symposium: Progress in Translational Urological Oncology Research Abstract: The 2014 American Urological Association (AUA) Urological Oncology Symposium, Progress in Translational Urological Oncology, will be held at the 2014 AUA Annual Meeting in Orlando, Florida on Friday, May 16, 2014 from 8:00 a.m. to 5:00 p.m. The meeting agenda is organized into two major topic sessions and a closing Special Topic Keynote presentation. The morning theme will focus on progress arising from the prostate cancer SPOREs with an emphasis on differentiation of indolent versus aggressive prostate cancer, and the afternoon theme will focus on progress from the renal and bladder SPOREs. The goals of both sessions are to catalyze translation of laboratory findings into clinical settings and vice-versa. Ample tim will be allotted for question and answer periods and networking. Speakers will consist of leaders drawn from the three Genitourinary SPOREs. Leaders of the AUA and its affiliated specialty societies, including the Society of Urologic Oncology (SUO) and the Society for Basic Urologic Research (SBUR), will be invited to attend. Scientific and program officers from the National Cancer Institute (NCI) will also be invited to attend. This application requests an award to help defray costs for the AUA Urological Oncology Symposium to be held on May 16, 2014 at the AUA Annual Meeting in Orlando FL. The support would provide travel awards for approximately 20 young investigators to attend the meeting, cover modest speaker honoraria ($200 each), and defray costs of meeting rooms and A/V needs. The focus of this symposium will be on the Genitourinary SPOREs with the intent of catalyzing translation of research findings to clinical application in prostate, bladder and kidney cancer. Up to 250 attendees are expected to participate in this program. The symposium seeks to create synergies and foster collaboration in urological oncology by bringing together scientists and clinicians at all career levels in a stimulating and interactive setting. We will actively recruit participation of new investigators, especially minorities and women, to this outstanding program.

Public health relevance
PUBLIC HEALTH RELEVANCE: Project Narrative: In 2014, the American Urological Association (AUA) will offer its second full-day Urological Oncology Program as part of "Research Friday" at the AUA Annual Meeting in Orlando, Florida. Research Friday marks the official start of the 2014 AUA Annual Meeting. The program is divided into three sections reflective of the three Genitourinary SPORE Programs: Prostate Cancer; Bladder Cancer; and Kidney Cancer; and each section will include rigorous and in-depth discussions of critical topic areas related to each Specific Aim. Application for the 2014 AUA Urological Oncology Research Symposium: "Progress in Translational Urological Oncology Research" Specific Aims: Based on information from ACS and NCI on prostate, bladder and kidney cancers: the total new cases for all is estimated for 2013 to be over 375,000; the total estimated number of deaths for all three is estimated to be over 58,000 people; and the collective economic burden of all three for 2010 was almost $20 billion. Thus, the public health relevance of this symposium, whose goal is to catalyze translation of laboratory findings in genitourinary cancers into the clinic, is very high. This symposium will attract leaders in the field, leading urology researchers, clinical urologists, and early career investigators to the AUA Annual Meeting, with the goal of advancing progress in urological oncology research. These interactions are expected to promote a better understanding of urological oncology at a molecular and cellular level, identify and develop new and more effective treatments, and develop potential translational pathways. The intent of the symposium is to create synergies and foster collaboration in genitourinary oncology by bringing together scientists and clinicians at all career levels in a stimulating and interactive setting. Te information discussed and shared during this meeting is expected to catalyze the translation of laboratory research to practical application. It is also intended to serve as a forum where young investigators have the opportunity to meet and interact with leaders in a host of disciplines related to prostate, bladder and kidney cancer. By learning more about these topics and the future of team science and personalized medicine from the most respected scientists in the world, all attendees will benefit from the state-of-the-art information provided and will become better equipped to formulate novel translational approaches that will lead to novel, impactful and effective treatments.